Precision metering and autonomous separation of blood components for pre-clinical microsampling at the point-of-care

PROJECT SUMMARY/ABSTRACT
Liquid venous blood is the gold standard for the majority of clinical assays, but it is unrealistic to expect it can be
collected at home or in remote locations due to the need for trained phlebotomists and the costs and logistics
related to cold chain transport. Approaches that enable patient-centric microsampling—where blood that is self-
collected by fingerstick can be sent ambiently through the mail—have the potential to address challenges with
specimen transport. However, the development of these technologies, typified by the century-old dried blood
spot (DBS) card, has not kept pace with the clinical need or emerging capabilities of telemedicine. The ability to
maximize the diagnostic test menu available to patients fundamentally relies on the successful transport of dried
blood or plasma to clinical laboratories. To make reliable clinical decisions, enable diagnoses, and inform
treatment decisions, there is an outstanding need for functional patient-centric devices that stabilize specimens
and enable measurements that are consistent with venous blood. Any solution must support two unique sets of
users: (i) Patients who desire access to routine tests for chronic conditions that would otherwise require them to
travel to receive care, and tests that provide personalized insight into their health status. (ii) Laboratories that
require high quality samples that do not introduce unpredictable sources of error into the quantitative
measurements that will be used to inform healthcare decisions, and processes that do not disrupt their current
analytical workflows. Previously, we demonstrated that patterning DBS cardstocks can create metered collection
zones for microsampled dried blood and plasma that support measurements of a wide range of analytes that are
equivalent to those made using liquid blood. Using our expertise in paper microfluidic devices, we propose the
development of paper-based microsampling devices that are designed to further close the gap between current
laboratory testing capabilities and ongoing patient needs by providing stable and metered samples of dried blood
and plasma to existing clinical workflows. Innovations in patient-centric, microsampling technologies will reduce
global disparities to access in healthcare, provide increased agency to patients desiring more information about
their health status, and support ongoing advances in telemedicine. We anticipate that the capabilities
demonstrated by our patterned dried blood and dried plasma spot cards will serve these needs and facilitate
improvements in patient care.

Public health relevance
PROJECT NARRATIVE Innovations in microsampling technologies have the potential to reduce global disparities to access in healthcare, provide increased agency to patients desiring more information about their health status, and support ongoing advances in telemedicine. The goal of this project is to develop a new suite of low-cost and patient-centric devices that enable the facile collection and precision metering of dried blood and dried plasma samples, improve integration of remote sample collection with testing in centralized laboratories, and ultimately impact patient care.